Serotonin Function and Receptor Imaging In Mood and Anxi

A variety of evidence suggests serotonin 1A (5-HT1A) receptor function is abnormal in panic disorder (PD), postraumatic stress disorder (PTSD), and depression. This protocol investigates the pharmacological basis for 5-HT1A abnormalities in vivo by applying positron emission tomography (PET) and the 5-HT1A receptor radioligand [F-18]FC-WAY100635 to assess 5-HT1A binding potential in panic disorder, postraumatic stress disorder, and unipolar and bipolar depression. Because central 5-HT1A receptor density is down-regulated in rodents by corticosterone administration and by stress-mediated corticosterone secretion, assessments of HPA-axis activity will be assessed to determine whether down-regulation of 5-HT1A receptors correlates with cortisol hypersecretion in PD, PTSD, and MDD. PET images of 5-HT1A binding are acquired in subjects who are unmedicated PD, PTSD and depressed patients, or are healthy volunteers. The 5-HT1A receptor volume of distribution (V) is calculated with a two tissue compartment model of PET data after a bolus infusion of ([F-18]FCWAY). The 5-HT1A receptor V in selected regions of interest (ROI) are the hippocampus, amygdala, ventral ACC, and orbital cortex, and are compared between the entire depressive and control samples. The relationships between 5-HT1A receptor V and salivary cortisol, and between 5-HT1A receptor V and cerebrospinal fluid concentrations of corticotrophin releasing hormone (CRH), are assessed by linear regression analysis. During the past year, an additional 22 subjects have been entered into this study for 5HT1A receptor imaging. We have developed satisfactory compartmental models for pixelwise determination of V and have developed a method for defining regions of interest that will be semi-automated and thus independent of operator bias. The image data are being analyzed. The results include showing prominent reducitons in 5HT1A receptor binding in the anterior and posterior cingulate cortices and the insula in bipolar disorder. The 5HT1A receptors in these regions play important roles in regulating emotional behavior. In addition, the neuropsychological assessments from this study comparing depressed and healthy subjects have shown deficits in the unmedicated unipolar and bipolar depressed patients that are consistent with dysfunction of the amygdala, ventral anterior cingulate cortex, and orbital cortex. Specifically, unmedicated depressed patients displayed deficits in inhibiting inappropriate responses to affective stimuli that was not present in the healthy control sample suggesting an attentional bias towards these stimuli. The unmedicated depressed sample also required more time to deliberate on a risk-based task, consistent with findings in frontal lesion patients. In another study 23 subjects with major depressive disorder whose depressive symptoms were in remission were imaged during serotonin depletion. This caused a transient relapse in most of these subjects, and PET scans of glucose metabolism were acquired in these subjects which revealed the areas which become metabolically active during a depressive episode. These results were published in the Archives of General Psychiatry. During the upcoming year the effects of serotonin transporter gene polymorphisms on this response will be characterized. Finally, the availability of a new serotonin transporter radioligand allowed us to begin characterizing the presynaptic portion of the serotonin system. A total of 12 subjects with unipolar depression, 6 subjects with bipolar depression and 17 healthy controls have been studied using this new method. This study will be completed during the upcoming one year.